Proteomic aging clock and brain structure, cognitive decline and the risk of Alzheimers Disease and related dementias

PROJECT SUMMARY
To assess biological aging before clinical diagnosis of Alzheimer’s Disease (AD) and Alzheimer's-disease-
related dementias (ADRD), we will create and validate proteomic aging clocks (PACs) in the prospective
population-based Atherosclerosis Risk in the Community (ARIC) cohort. The blood proteomics measures have
been collected three times over 20 years of follow-up using highly sensitive SomaScan assay. PACs are easily
measured, can accurately predict the aging process, and are associated with age-related diseases and
mortality. Our main objectives are to create and validate PACs in AD/ADRD-free participants and test whether
these PACs predict risk of ADRD, cognitive decline and structural abnormalities visible in brain imaging such
as parenchymal loss, white matter hyperintensities, and small infarcts. We will assess two published PACs and
create two new PACs: (1) PAC based on the association with chronological age in AD/ADRD-free persons of
mixed age, and (2) PAC based on the change in protein levels between midlife and late-life (Aim 1). Further,
we will test whether higher PAC value (independent of chronological age) and higher intra-individual difference
in the PAC values from midlife to late-life are associated with higher risk of AD/ADRD (Aim 2), and with decline
in cognitive function and with structural abnormalities visible in brain imaging in late-life (Aim 3). All the
associations will be stratified by sex and race. The use of existing ARIC data will allow for quick and cost-
efficient testing of our hypotheses. The quantification of PAC and clarification of its relations with AD/ADRD are
essential for understanding the role of aging in the pathobiology of this disease, identifying individuals at high
risk, and efficiently delivering personalized prevention/treatment via lifestyle change and anti-aging therapies.

Public health relevance
PROJECT NARRATIVE Development of blood-based measurement of biological aging will improve our understanding of the role of aging in Alzheimer's disease and Alzheimer's disease-related dementias (AD/ADRD) and subclinical structural brain changes and cognitive decline before the clinical onset of AD/ADRD. Our study will inform on novel strategies for the preclinical screening of AD/ADRD. The accurate assessment of biological aging may help facilitate the development of anti-aging therapies against AD/ADRD.